P30 Core Grant for Vision Research

PROJECT SUMMARY: CENTER CORE
The vision science research program at the University of Illinois at Chicago (UIC) has been supported by one of
the longest-running core grants from the National Eye Institute (NEI). The overarching goal of the Center Core
Grant for Vision Research is to support, strengthen and expand basic and translational vision science research
at UIC. A major advantage of the Center Core Grant is that it facilitates inter-disciplinary and inter-departmental
scientific interactions and collaborations among members of the Vision Science Research Community (VSRC).
Current VSRC investigators hold a total of 25 NEI-funded research grants, of which, 16 are qualifying R01s.
The Center Core Grant resources have significantly impacted performance of pioneering research in wide-
ranging and clinically-relevant areas. These resources have enhanced research capabilities and productivity of
individual investigators, created an environment conducive to resource-sharing and collaborative scientific
interactions, assisted new investigators to develop research projects, and aided established NEI R01-funded
investigators to pursue research in emerging fields. This renewal Center Core Grant application responds to
the evolving research needs of participating investigators and requests funding to support 4 resource Cores:
Cellular and Molecular Biology Core, Imaging and Image Analysis Core, Animal Services Core, and
Translational Core for Therapeutic and Diagnostic Development. These resource Cores provide exceptional
facilities, cutting-edge bioinstrumentation, and experienced technical expertise in molecular biology, cellular
biology, histology, proteomics, genomics, imaging, disease modeling, biostatistics, data science, and artificial
intelligence services. The Center Core Grant will continue to sustain and promote conduct of exemplary basic
and translational inter- disciplinary and collaborative vision science research. It will provide the essential
catalysts needed to collectively advance knowledge of the biology and pathophysiology of the visual system
and develop novel diagnostic and therapeutic approaches for prevention of vision loss.

Public health relevance
PROJECT NARRATIVE: CENTER CORE The Core Grant for Vision Research provides shared resources that are accessible to a group of independently funded investigators to enhance their research capability and productivity and create an environment conducive to collaborative scientific interactions for inter-disciplinary and translational vision science research to advance knowledge of the visual system and its disorders.